Screening for AL Amyloidosis in Smoldering Multiple Myeloma

Abstract
Our objective is to develop tools that improve early diagnosis of systemic light-chain (AL) amyloidosis, a disease
that causes heart and kidney failure and early death, in patients with smoldering multiple myeloma, a disease in
which patients make immunoglobulin free light chains but are relatively asymptomatic. Based on a retrospective
study in members of the US Armed Forces who developed AL, there is a 10 to 15 year precursor period prior to
patients presenting at a median age of 63 with symptoms of AL due to toxic free light chains (FLC) and amyloid
deposits. In similar studies of patients with smoldering myeloma we know that 2% of them develop AL, meaning
that 2% have FLC that are markedly abnormal. Over half of new AL patients present with heart involvement and
it is the failure to diagnose early that underlies their 20% mortality within 6 months. In this application, we seek
support to screen patients with smoldering multiple myeloma for undiagnosed AL and risk of AL using a series
of criteria that will increase our knowledge of the likelihood of having undiagnosed AL or of being at risk for AL.
Only efforts to diagnose AL and determine risk of AL in the precursor phase of the disease will reduce the early
mortality rate. Our goal is to develop a likelihood algorithm for undiagnosed AL and risk of AL in smoldering
myeloma patients and our aims in this application are to create a network to enroll 340 patients with smoldering
multiple myeloma (SMM) on a collaborative study requiring marrow and blood specimens and collection of data
for a training set of likelihood statistics and to plan the future validation study and to validate an next generation
sequence (NGS) assay that identifies IGVL genes in clonal plasma cells. The clonal κ and λ IGVL genes in AL
cases are restricted AL-related sets of genes. The likelihood algorithm will employ 5 parameters: (1) the presence
of SMM; (2) a difference between involved (pathologic) and uninvolved FLC > 23mg/L; (3) clonal plasma cell
cytogenetics showing t(11;14) or gain 1q, (4) AL-related κ or λ IGVL genes by NGS, and (5) NT-proBNP >
332pg/mL. All subjects will have their clonal IGVL genes identified by NGS enabling the creation and validation
of a laboratory developed test in a precision medicine laboratory that is certified under regulations of the Clinical
Laboratory Improvement Amendments of 1988 (CLIA). Our long-term goal is to overcome the current inability in
patients with SMM to effectively assess for the presence of occult AL or to estimate the likelihood of developing
AL. By determining the values of the 5 parameters we will create the training set for an algorithm to estimate the
likelihood of having or progressing to AL and will be able to design the validation study. We have assembled a
collaborative team of investigators at centers across the USA to pursue our aims and an expert support group
to address the opportunities, challenges and patient care issues that will arise. We have put together a team of
expert collaborators from over a dozen academic centers and expert consultants in myeloma, AL amyloidosis,
molecular biology and protein biology, in order to pursue these aims, realizing the complexity of the endeavor
and the demands of each aim.

Public health relevance
Public Health Statement Our objective is to develop tools that improve early diagnosis of systemic light-chain (AL) amyloidosis, a disease that causes heart and kidney failure and early death, in patients with smoldering multiple myeloma, a disease in which patients make immunoglobulin free light chains but are relatively asymptomatic. By studying patients with smoldering myeloma and analyzing their light chain levels, the genes in their myeloma cells and a certain heart-related protein we will be able to establish the likelihood that they have or will get AL.